WHO COLLABORATING CENTER FOR EPIDEMIOLOGICAL AND CLINICAL INVESTIGATIONS

The Phoenix Epidemiology and Clinical Research Branch was designated as the WHO Collaborating Center for Design, Methodology and Analysis of Epidemiological and Clinical Investigations in Diabetes in 1986. The purposes of the Center are to collaborate with the World Health Organization in the implementation of the WHO/IDF action program to provide advice, consultation and collaboration with other investigators in the design, methodology and analysis of epidemiology and clinical diabetes (NIDDM) and its complications. The center will assist in the development and application of standardized methods for epidemiological and clinical investigations relating to the etiology and pathogenesis of non-insulin- dependent diabetes (NIDDM) and its complications. The center will assist in the development and application of standardized methods for epidemiological and clinical investigations, and data analysis relating to diabetes and collaborate with those interested in applying such techniques elsewhere. The Center will advise and help in the design of new studies, including on site assistance when necessary. The Center serves to train investigators from many parts of the world in diabetes epidemiology and clinical research. The Center participates in the WHO Multicenter Study of Vascular Disease in Diabetes, which is examining the mortality and incidence of vascular complications of diabetes among different ethnic groups in different countries.